Center for Childhood Obesity Prevention

PROJECT SUMMARY Childhood obesity is a growing threat to public health in the United States. The goal of the Center for Childhood Obesity Prevention (CCOP) at Arkansas Children's Research Institute (ACRI) is to reduce childhood obesity rates in children through integrated, interdisciplinary and translational research. In line with the goals of the Centers of Biomedical Research Excellence (COBRE) funding mechanism, to support the establishment and development of innovative, state-of-the-art biomedical research centers at institutions in Institutional Development Award-eligible states, the CCOP has established a Metabolism and Bioenergetics Core (MBC) to make critical biomedical research services available to CCOP investigators. This instrumentation supplement application will be used to purchase a rodent metabolic and behavioral phenotyping system. This key instrumentation will allow the MBC to provide important rodent phenotyping services to CCOP investigators. Accordingly, this supplement will significantly enhance access for CCOP investigators to state-of-the-art metabolic and behavioral phenotyping instrumentation. Beyond obesity, alterations in how our bodies metabolize and partition fuel is linked to the etiology of several chronic diseases. Accordingly, platforms that accurately determine rodent feeding behavior, activity, substrate metabolism and energy expenditure in real-time provide a wealth of important phenotypic data that increase the impact of basic research employing rodent models. Since ACRI is home to two National Institutes for General Medical Sciences COBRE awards, this instrumentation supplement is well positioned to significantly enhance the impact of numerous NIGMS funded research projects by enhancing access to critical instrumentation.

Public health relevance
PROJECT NARRATIVE Childhood obesity is becoming more prevalent in the United States, meaning robust data-driven approaches are needed to prevent excess weight gain and promote metabolic health in children. This administrative supplement will be used to purchase of a rodent metabolic and behavioral phenotyping system to increase the access of Center for Childhood Obesity Prevention (CCOP) investigators at Arkansas Children's Research Institute to state-of-the-art instrumentation platforms. Providing a platform to accurately determine feeding behavior, exercise habits, substrate metabolism and energy expenditure in real-time will increase the translational value of preclinical research focusing on the biology of obesity.